ADULT LEUKEMIA RESEARCH CENTER

The marrow transplant program is a major part of the clinical program of the Center. The purpose of the administrative section of this program project grant is to insure that the resources to carry out the proposed research are available and accounted for. In a program this large, close cooperation between investigators and administrative staff is mandatory for successful completion of the proposed research. An administrative structure has been designed to perform this task.